Defining and treating genetic abnormalities in psoriasis/atopic dermatitis-overlap dermatoses

Defining and treating genetic abnormalities in psoriasis/atopic dermatitis-overlap dermatoses
Project Summary/Narrative
Immunomodulatory therapies now robustly improve cases of the inflammatory skin diseases psoriasis and
atopic dermatitis, based on selective targeting of cytokine pathways. However, no biomarkers are available to
diagnose or predict treatment regimens for the frequent, ambiguous rashes harboring overlapping
clinicopathologic features of both diseases. The objective of this proposal is to use high-resolution, quantitative
biomarkers specific for psoriasis and atopic dermatitis to understand the etiology of these overlap cases, which
we term “PSO-AD” rashes. We will also use observational studies to determine if PSO-AD rashes predictably
respond to targeted drugs based on their biomarker profile. Our long-term objective is to develop a biomarker
that can predict the medication most likely to elicit clinical improvement in a given patient's PSO-AD rash. Our
central hypothesis is that PSO-AD rashes arise from a spectrum of genetic abnormalities and that cases
closely resembling psoriasis or atopic dermatitis will respond to the corresponding targeted medication. The
rationale underlying this proposal is our preliminary data defining highly specific biomarkers for psoriasis and
atopic dermatitis and evidence that based on these markers, therapies can be rationally chosen for PSO-AD
overlap cases. We will pursue these aims using innovative technical approaches that include spatial
transcriptomics (to validate that epidermal pathology arises from T cell pathology) and targeted bulk RNA-seq
methods that can assess PSO-AD cost effectively on the patient level. Our proposal is significant because it
advances the first companion diagnostic to targeted biologic medications.The expected outcome of this
proposal is a biomarker set that predicts drug response in PSO-AD rashes. These data will have a positive
impact on treatment because they will reduce the substantial clinical delays and economic impact stemming
from failed ad hoc treatment of PSO-AD rashes.

Public health relevance
Project Narrative The proposed project is relevant to public health because it seeks biomarkers that differentiate complex inflammatory skin diseases, better directing existing treatments and reducing the expense and morbidity stemming from failed treatments. Thus, this proposal is relevant to the part of NIH's mission that addresses technological innovations and clinically directed research strategies as a basis for improving human health.